Melanoma: Metabolic Biomarkers of Response to Targeted Therapy

Melanoma: Metabolic Biomarkers of Response to Targeted Therapy
Project Summary/Abstract
Disseminated metastatic melanoma is initially treated with inhibitors of the V600E mutated BRAF kinase, a
component of the MAPK signaling pathway that controls the replication of melanoma cells. More than half of
melanoma patients express this mutation and are at least initially responsive to its inhibition. However, all pa-
tients eventually become resistant to these inhibitors and have to be treated with alternate therapy, which con-
sists primarily of immune checkpoint inhibitors. The goal of this project is to develop an imaging method that
could monitor the effectiveness of BRAF kinase inhibitors and can promptly and accurately detect resistance to
these agents. Our strategy for achieving this goal is to study the detailed biochemical mechanism of BRAF ki-
nase signaling on the premise that a change in tumor metabolism is a quicker and more reliable indicator of the
onset of resistance than a change in tumor volume, which can require weeks to months to become reliably
manifest. We will use 13C MRS and liquid chromatography mass-spectrometry (LC-MS) to study the mecha-
nism of BRAF metabolic inhibition, but these methods are not suitable for in vivo detection in humans – 13C
MRS is not sensitive enough and LC-MS is invasive. Therefore, our strategy is to identify suitable biomarkers
of metabolic response that can be monitored by 1H MRS or MRI monitored chemical exchange saturation
transfer (CEST), which is about 500 times more sensitive than 1H MRS but requires high magnetic field instru-
ments operating at ≥ 7T. In contrast, 1H MRS can be monitored at 1.5T or 3T, for which instruments are avail-
able at many more medical institutions. Our second objective is to delineate how the biomarkers of BRAF inhi-
bition work in order to better appreciate their capabilities and limitations. Finally, preliminary data from our own
lab and from others indicates that the onset of resistance to mutant BRAF inhibitors involves a transition of the
tumor from dependence on aerobic glycolysis to substantially greater dependence on ox-phos and on glutami-
nolysis. This has led to clinical trials of the use of inhibitors of ox-phos such as metformin and phenformin to
delay the onset of resistance. As our third objective, we propose to test the feasibility of using CB-839, an in-
hibitor of glutaminase to block the transition to glutamine-dependence as a method to inhibit the onset of BRAF
resistance. Our Specific Aims are: Aim 1 will determine biochemical changes and effectiveness of MAPK
pathway inhibition in murine and human models of melanoma. Aim 2 will elucidate substrate limitations on bio-
chemical effects and biomarker response to changes in microenvironment. Aim 3 will validate the proposed
biomarkers in an in vivo system where the treatment response is modified using a glutaminase inhibitor.
Clinical Impact: This project will enable detection of melanoma response to targeted therapy by NMR meth-
ods that have already been implemented in the clinic on conventional 1.5T and 3T instruments and on 7T in-
struments that are becoming progressively more common. Metabolomic studies will expand our ability to quan-
tify tumor metabolism in cells, in mouse and human models, and eventually in humans.

Public health relevance
Melanoma:Metabolic Biomarkers of Response to Targeted Therapy Project Narrative Melanoma is currently treated with an inhibitor of a signaling protein that sends signals for the tumor cells to proliferate. While this method is initially effective in most patients, all patients eventually become resistant to this drug and have to be treated with other agents. The goal of this project is to develop an imaging method that detects the onset of resistance to this drug and indicates when treatment should be switched to an alternate drug. The study will also investigate if including a glutaminase inhibitor in the initial treatment regimen can increase or prolong effective therapy.